Factors associated with Refractory and Early Recurrent Bacterial Vaginosis

Bacterial Vaginosis (BV), a disorder of the vaginal microbiota characterized by low levels of protective
Lactobacilli and higher abundance of a variety of anaerobic bacteria colonizing the vagina, is the leading cause
of vaginal complaints in cis-gender women and associates with increased risk of preterm birth and HIV and STI
acquisition. Recommended first-line BV therapies include oral or vaginal metronidazole or vaginal clindamycin,
although most are treated with metronidazole; clindamycin is much less frequently used. It is well known that
60% of BV recurs within 1 year after antibiotics. What is less appreciated, however, is that a significant
proportion of patients may experience poor outcomes (either persistent, refractory BV [refBV] or early
symptomatic recurrence [erBV]) within 6 weeks after standard BV therapy. Defining vaginal micro-
environmental factors at the time of symptomatic BV (sBV) diagnosis that associate with subsequent ref or
erBV, could provide critical insights into disease pathophysiology and inform the development of candidate
clinical biomarkers to predict these conditions. In the long term, this could change clinical practice by
identifying a priori those for whom standard BV treatments are likely to be inadequate, who may need more
aggressive initial therapy with regimens currently reserved only for those with demonstrated recurrent BV (≥3
recurrences in 12 months), [e.g. alternative or higher dose antibiotics, intra-vaginal boric acid, suppressive
antibiotics, or novel bio-therapeutics currently under development.] Early data suggest vaginal microbiota
features, or a disordered immune response may predict ref or erBV. Additionally, virulence factors of specific
BV-associated bacteria may lead to vaginal epithelial cell (VEC) damage, revealing deeper (immature) VEC
layers and resulting in decreased glycogen to support Lactobacillus growth, increasing risk of ref or erBV. Long
term, deciding which adjunctive treatments to use or to develop for those at risk of poor outcomes early after
therapy will depend on understanding underlying biologic mechanisms driving disease. The focus of this grant
is to identify vaginal microenvironmental factors associated with ref or erBV. Our work will also establish a
sample repository to be used for future studies to characterize the pathophysiology of ref and erBV. We
propose to recruit a cohort of patients diagnosed with acute BV and follow them over 6 weeks to accomplish
these Aims: 1. Establish a prospective cohort and specimen repository from individuals with refBV, erBV and
early remission. 2. Using advanced metagenomic techniques, compare the vaginal microbiome at sBV
diagnosis prior to treatment in those who experience ref and erBV vs. early remission. 3. Assess mucosal
immunologic profiles, vaginal glycogen and VEC maturity at sBV diagnosis in those who experience ref and
erBV vs. early remission. The study will be fully powered to assess aims in those initiating metronidazole (the
most commonly used therapy) for acute BV. This research will identify candidate predictive biomarkers for ref/
erBV, and, long term, will provide data to inform mechanistic and interventional studies to improve BV care.

Public health relevance
A significant proportion of patients may experience poor outcomes (either refractory or recurrent disease) within 6 weeks after standard antibiotic treatment for bacterial vaginosis (BV). Finding baseline vaginal micro- environmental factors associated with these early adverse outcomes could produce candidate biomarkers for these conditions, and ultimately change clinical practice by identifying patients who may require more aggressive initial therapies. Here, we propose to recruit a cohort of patients initiating therapy for acute BV and follow them over 6 weeks to identify vaginal microenvironmental factors associated with refractory or early recurrent BV resultant specimen repository may also be leveraged for future studies to reveal underlying mechanisms (and ultimately improved treatments) for these conditions.